Medial Arterial Calcification in Peripheral Artery Disease

PROJECT SUMMARY
Peripheral artery disease (PAD) is highly prevalent in older adults and is a comorbidity to diseases such as
diabetes, chronic kidney disease, and hypertension. For decades PAD was assumed to be mainly an
atherosclerotic pathology, however emerging data establish medial arterial calcification (MAC) as a distinct
disease state of PAD, independent from atherosclerosis. The mechanisms driving MAC pathogenesis are
unclear. We previously discovered the rare disease Arterial Calcification due to Deficiency of CD73 (ACDC),
where homozygous inactivating mutations in the gene encoding the CD73 enzyme cause MAC in otherwise
healthy adults. We recently found that a lack of CD73 and its product adenosine promotes FOXO1 nuclear
location and FOXO1-dependent activation of the mineralizing enzyme, tissue non-specific alkaline phosphatase
(ALPL/TNAP) gene promoter. Pharmacological inhibition of FOXO1 blocked TNAP activity and calcification in
vitro. Importantly, we found that this CD73/FOXO1/TNAP axis was present in non-genetic common forms of
MAC, indicating that CD73 is critical for peripheral vascular health. There are significant gaps in our
understanding of MAC pathogenesis, and the causes and consequences of reduced CD73 and its product
adenosine in this disease state. This proposal will test the central hypothesis that CD73 levels are suppressed
as a consequence of activation of the DNA damage response, and that reduced CD73-mediated adenosine
production alters arginine methylation to promote FOXO1-induced osteogenic gene transcription in SMCs.
Aim1 will define the mechanisms by which the DNA damage response promotes vascular calcification. Aim2
will determine how reduced adenosine production alters arginine methylation and promotes the upregulation
of osteogenic transcriptional programs in SMCs. We expect the completion of these complementary studies
will identify a novel, druggable pathway driving MAC pathogenesis in PAD.

Public health relevance
PROJECT NARRATIVE Medial arterial calcification is widespread in the adult population and strongly correlates with the occurrence of major cardiovascular events and premature death. This research aims to investigate the underlying causes of medial arterial calcification and determine the cellular events that promote a vascular cell to calcify. This work may identify novel targets that can be leveraged to develop treatments to prevent, halt, or even reverse the vascular calcification seen in elderly patients and those with diseases like arteriosclerosis, diabetes, and chronic kidney disease.